The Mutant Mouse Resource and Research Center at the University of Missouri - Resource

PROJECT SUMMARY - RESOURCE
The Mutant Mouse Regional Resource Center (MMRRC) at the University of Missouri (MU) provides a unique
repository service by importing, storing and distributing mutant mouse strains, cryopreserved germplasm,
embryonic stem cells and related reagents as well as performing research to continuously improve the use of
mouse models in research. Genetically-engineered mice (GEM, i.e., transgenics, knock-outs and knock-ins)
are invaluable to almost all fields of medicine. Tens of thousands of GEM have been created over the last
three decades to facilitate better understanding of developmental biology and disease and to test and improve
the function of drugs and therapeutics. Since the MMRRC network began, it has evolved into a major resource
for the research community with capabilities and a combined inventory of mouse lines and embryonic stem
(ES) cells that exceeds the capacity of other mouse repositories worldwide. The overall goal of this proposal is
to continue the existing services and expand the functions and capabilities of the MU MMRRC. The specific
aims are to 1) provide biomedical investigators with the mouse models and related reagents they require for
their research, 2) provide value-added services to aid the biomedical research community, and 3) perform
research that has broad application to all models distributed. Over the next five years, the MU MMRRC will
continue to rederive imported mice to a pathogen-free state; cryopreserve gametes and embryos; perform
genetic and infectious disease monitoring to ensure quality; and distribute live mice, cryopreserved germplasm,
tissues, and embryonic stem cells. Research efforts will continue to assess the role of complex gut microbiota
in model phenotypes and model reproducibility and translatability by developing well controlled antigen-
experienced microbiota, economic strategies by which complex microbiota can be transferred, and tools to
better sample microbiota kinetics. These studies will yield new paradigms by which the MMRRC can provide
mice (i.e. harboring one or more standardized complex microbiota) and refine value added services that will be
made available to the biomedical research community. The MU MMRRC will also continue to transition to a
self-sustaining unit by offering an increasing number of services that generate program income. Services
include cryopreservation, cryoresuscitation from embryos or sperm, rederivation, genotyping and assay
development, marker-assisted genetic analysis for development of speed congenics, karyotyping, colony
management, phenotyping, and microbiome manipulation and analysis.